Translational Control of Conidial Germination in Aspergillus fumigatus

PROJECT SUMMARY/ABSTRACT
Aspergillus fumigatus is a major human fungal pathogen capable of causing a range of diseases, including
invasive pulmonary aspergillosis and disseminated aspergillosis in a wide variety of immunocompromised
individuals, including organ transplant recipients and cancer patients. Mortality rates are as high as 40-50% in
these patients and direct healthcare costs associated with invasive aspergillosis, $4.6 billion in the U.S., are
more than those of any other fungal infection. A. fumigatus, normally found in the soil and environment,
produces asexual conidia that are typically inhaled in the lungs. Under appropriate host environmental
conditions conidia will germinate and eventually form hyphae that can not only penetrate lung tissue but also
establish a disseminated bloodstream infection. Conidial germination is thus critical for A. fumigatus virulence
and pathogenesis. While a variety of post-translational and transcriptional regulators are known to play
important roles in conidial germination, very little, if anything, is known about translational mechanisms.
However, multiple lines of evidence suggest that translational regulation plays an important role, including the
demonstration that conidial germination can be abrogated by inhibitors of translation, but not RNA or DNA
synthesis, that dormant conidia harbor a significant number of stored transcripts, which are primed for rapid
translation and activation, and that translation is one of the earliest detectable events in germinating conidia. In
addition, a comparative proteomic and transcriptomic study indicated that many genes show significant
differences in transcript vs. protein expression changes during A. fumigatus conidial germination and
transcripts of several key regulators of this process possess unusually long 5’ UTR regions, which have been
associated with translational regulation of morphology and other virulence processes in the human fungal
pathogen Candida albicans. We have also recently used ribosome profiling to demonstrate that the C. albicans
yeast-hyphal morphological transition, which is similar to A. fumigatus germination/polarized growth, is under
widespread global translational regulation that does not simply parallel transcriptional regulation; many genes
associated with virulence and virulence-related processes show altered translational efficiency. Based on this
evidence, we hypothesize that translational mechanisms play an important role in controlling A. fumigatus
conidial germination, distinct from that of transcriptional mechanisms, which will reveal novel potential
antifungal targets. In order to test this hypothesis, we will: 1) determine the global translational profile of A.
fumigatus during conidial germination, 2) identify and characterize translational mechanisms important for A.
fumigatus conidial germination. Ultimately, this study will provide a better understanding of global regulatory
circuits and pathways controlling A. fumigatus conidial germination at the translational level. This study will also
identify and characterize several key translationally regulated factors important for A. fumigatus conidial
germination that could potentially serve as targets for novel and more effective antifungals.

Public health relevance
PROJECT NARRATIVE Relevance to public health: Aspergillus fumigatus, a major human fungal pathogen and leading cause of invasive aspergillosis, can infect a wide variety of immunocompromised individuals and represents a significant threat to global public health. This application will determine how translational efficiency mechanisms control conidial germination, an important virulence property of A. fumigatus. Ultimately, this study will provide a better understanding of global translational regulatory circuits and pathways that regulate A. fumigatus conidial germination as well as identify and characterize several key factors important for this process that could potentially serve as targets for the development of novel and more effective antifungal strategies.